PHASE I STUDY OF BMS188667 (CTLA4IG) IN PATIENTS WITH PSORIASIS VULGARIS

The objective of this study is to assess the safety of CTLA-4 Ig intravenously administered to patients with psoriasis. In addition to the safety assessment, clinical efficacy in psoriasis is being determined.